Reducing Necrotizing Enterocolitis Disparities with a Neonatal Project ECHO

ABSTRACT
Despite the widespread availability of low-cost, evidence-based preventative strategies like human milk
feeding, feeding guidelines and medication stewardship, necrotizing enterocolitis (NEC) remains a chief cause
of emergency surgery and death in premature infants and disproportionately affects Black and Hispanic
infants. Under-resourced neonatal intensive care units (NICUs) struggle to support staff education, a culture
that engages in quality improvement (QI), or access essential resources like donor human milk and adequate
nursing care. The intersectionality of these factors in concert with social determinants of health may contribute
to NEC disparities. NICU disparities are lessened with intense quality improvement, although equity-focused
quality improvement is rare. In 2016, the U.S. Legislature signed the “Expanding Capacity for Health Outcomes
(ECHO) Act” into law to spur “technology-enabled collaborative learning and capacity building models” and
accelerate the impact of these models on preventing disease and improving public health outcomes among
underserved groups. Our team has effectively implemented a neonatal Project ECHO (NeoECHO) which
supports implementation of NEC preventing best practices and our team has shown its benefits to reach NICU
clinicians in under-resourced settings. Using a stepped-wedge clinical trial design and engagement of patient-
family advocate partners and a national neonatal practice group, we will provide active facilitation via tele-
mentoring and working with local internal facilitators in 30 NICUs to examine the effects of a NeoECHO
approach to reduce NEC rates and impacts on NEC disparities within and across units. Aims will: 1) Compare
the effectiveness of NeoECHO to usual care on NICU-level outcomes for NEC and clinical care. 2) Describe
the structural organizational contexts and unit-level differences in quality outcomes at baseline and examine
their contribution to intervention effectiveness. 3) Evaluate NeoECHO implementation (including features of
engagement, reach, number of recommended practices adopted and embedded in practice, retention of NICUs
in the program, effect on clinician confidence, and cost). Using an implementation determinant framework
known as the Health Equity Implementation Framework, we will qualitatively explore the barriers and
facilitators to implementation of NeoECHO to allow for a more contextual understanding of implementation
disparities. Our pragmatic, experimental design will expand the evidence base on both effectiveness and
implementation of ECHO and contribute to the AHRQ mission by addressing modifiable risk factors to reduce
disparities in the incidence of NEC; leveraging telehealth-delivered mentoring to facilitate adoption of EBP by
removing accessibility barriers; and offering at-the-shoulder support for NICUs most in need. This application is
responsive to the AHRQ Special Emphasis to Advance Health and Healthcare Equity (NOT-HS-23-013),
informing the advancement of equitable neonatal healthcare quality using implementation science.

Public health relevance
PROJECT NARRATIVE Necrotizing enterocolitis (NEC) disproportionately affects people of color and is a significant cause of emergency surgery and death among fragile infants. This project, using a telehealth-delivered mentoring intervention called "NeoECHO," aims to provide evidence of its effectiveness in adopting NEC prevention measures and gather information on structural differences in neonatal intensive care units (NICUs) to ultimately eliminate NEC disparities.